BISPHOSPHONATES ON BONE DENSITY IN PTS W/ CYSTIC FIBROSIS

The purpose of this research study is to determine if osteoporosis in cystic fibrosis patients before or after lung transplantation can be reversed, at least in part, by vitamin D and calcium with or without pamidronate. If these therapies are effective, less fractures will occur and quality of life will be improved.